Innate immune dysregulation in alcohol-associated liver disease

ABSTRACT
Alcohol-associated hepatitis (AH) is the most severe manifestation of alcohol-associated liver disease that is
characterized by hepatocyte dysfunction, systemic inflammation and poor clinical outcomes. We recently
reported heterogeneity in neutrophils in AH with over-activated, high-density (HDN), and functionally exhausted,
low density (LDN) neutrophil populations that contribute to liver damage. We hypothesize that neutrophil
dysfunctions in AH are related to neutrophil heterogeneity and functional differences between neutrophil
populations. We found that the alcohol-induced LDNs are generated in vivo in AH patients from HDNs after
extracellular traps (NETs) release. However, the phenotype and function of these LDNs are yet to be delineated
in AH. Efferocytosis, that is a process for removal of NETs, is decreased by alcohol and our preliminary data
suggest that LDNs express high levels of CD47, a “do not eat me” signal and CD24, a signal that prevents cells
to undergo apoptosis, permitting longevity of LDNs in AH. We hypothesize that alcohol-induced CD47 contributes
to neutrophil’s longevity and immunosuppressive effects. Our preliminary results suggest that alcohol-induced
neutrophil activation and NET release are associated with activation and phosphorylation (pBTK) of the Bruton’s
tyrosine kinase (BTK). We postulate that pBTK is a molecular regulator of alcohol-induced NET release and LDN
generation. Finally, we propose that neutrophil-specific inhibition of BTK will ameliorate neutrophil-mediated
inflammation and liver damage. The Aims are #1: To explore neutrophil phenotypes through characterization of
their transcriptomic profiles and functional roles in severe alcohol-associated hepatitis by a) single cell RNAseq
in patients with AH; b) characterizing surface marker expression and function of neutrophil populations in AH; c)
determine whether LDNs are a causal factor in AH or a consequence of AH. Aim#2 will test the role of CD47, a
“do not eat me” signal, and CD24, a signal to prevent apoptosis, on neutrophil dysfunction, inflammation and
liver damage in AH by assessing the effects of alcohol on CD47 and CD24 expression and function in circulating
neutrophil populations and in the liver and by testing the effect of CD47 deficiency or administration of anti-
CD47 and/or anti-CD24 blocking antibodies on neutrophil heterogeneity, function and liver damage in vivo in a
preclinical model of AH. Aim#3 will evaluate the role of alcohol-induced BTK phosphorylation in neutrophil
dysfunction and explore BTK-targeting therapeutic interventions in a preclinical model of AH by a) defining the
role of BTK activation and its interactions with STING/IRF3 in neutrophil heterogeneity, NET induction and LDN
generation; b) testing the effect of neutrophil-specific deletion of BTK in a mouse model of AH. Our results will
reveal unique heterogeneity of neutrophils in AH and provide better understanding of the controversial roles of
neutrophils in AH. The proposed studies will provide novel insights into the role of BTK at in neutrophils and AH
and define its interactions with other key signal transduction pathways that may identify BTK, CD47 or CD24 as
new therapeutic targets for amelioration of AH.

Public health relevance
PROJECT NARRATIVE Alcohol-associated hepatitis is a devastating disease with poor clinical outcomes. In this study, we will evaluate phenotypic differences in neutrophils and their functional abnormalities in alcohol-associated hepatitis. Our study will also discover the novel role of low-density neutrophils in alcohol-associated liver disease, and the mechanistic role of Bruton’s tyrosine kinase, a signaling molecule that we newly discovered to be highly activated in alcohol-associated hepatitis in regulating neutrophil phenotype and function. We will assess whether targeting immuno-inhibitory molecules on neutrophil populations could be feasible therapeutic targets for amelioration of alcohol-associated hepatitis.